Therapeutic rescue of the transcriptional repressor Capicua to inhibit lung cancer metastasis

Project Summary Abstract
Candidate: Ross Okimoto, MD is a medical oncologist who believes that disease focused basic science research can
improve outcomes for patients with cancer. Dr. Okimoto's long-term goal is to lead an independent laboratory-based
translational research program aimed at identifying and targeting the molecular underpinnings of cancer metastasis.
With two recent first author publications in Nature Genetics and PNAS, Dr. Okimoto has demonstrated potential as a
translational cancer researcher. This K08 application will be critical for his ongoing career development, providing him
with key mentorship and training in 1) oncogene mediated transcriptional regulation of normal and malignant
progression; 2) advanced microscopy techniques; and 3) employing disease specific preclinical tools to enhance
therapeutic modeling and enable clinical translation.
Research: Metastasis accounts for >90% of cancer related death, yet the ability to inhibit the spread of cancer is
hindered by the lack of pro-metastatic targets and robust preclinical models that recapitulate human disease. Through
development of an in vivo orthotoptic lung cancer metastasis model, Dr. Okimoto recently found that the transcriptional
repressor, Capicua (CIC), suppresses lung cancer metastasis. Since the candidate found that CIC expression is
decreased upon ERK activation, he hypothesizes that ERK inhibition can restore CIC expression to block metastasis.
The following specific aims are proposed: 1) to test if CIC is a direct physical and functional substrate of ERK signaling;
2) to test if MEK-ERK inhibition restores CIC expression to inhibit metastasis in a well-defined orthotopic mouse model.
Mentorship and Training: Dr. Okimoto's training will be accomplished through formal coursework and under direct
mentorship of world leaders including Trever Bivona, MD, PhD, a thoracic oncologist with expertise in molecular
targeted therapies. Dr. Bivona has extensive research support from the NIH (3 NCI-funded R01's and the DP2 Directors
New Innovator's Award), and has mentored five fellows to independence within the past five years. Dr. Okimoto will be
co-mentored by Zena Werb, PhD, an expert in transcriptional metastatic regulation. Dr. Werb was the recipient of the
UCSF Lifetime Achievement in Mentoring Award in 2015, recognizing her devotion to mentoring young physician-
scientist to independence. In addition to his mentorship committee, Dr. Okimoto has assembled a word class team of
physician-scientist advisors including, Kevin Shannon, MD (expert in mouse models and MAPK signaling), Andrei Goga,
MD, PhD (oncogenic transcriptional control), and Neil Shah, MD, PhD (preclinical/clinical therapeutics) to provide
guidance and to ensure he succeeds in transitioning into an independent physician-scientist.
Environment: The candidate's training and research will be performed at the University of California, San Francisco, a
world-renowned center of excellence in translational medicine and research. Dr. Okimoto will be provided with all the
institutional resources necessary to complete the proposed experiments in a well-integrated community of physicians
and scientists. Successful completion of the proposed research will provide preclinical rationale to use clinically
approved MEK-ERK inhibitors to block lung cancer metastasis in a patient population with few therapeutic options.

Public health relevance
Project Narrative Metastasis accounts for >90% of cancer-related deaths. Despite it's immense clinical impact, the molecular determinants of metastasis remain undefined, largely due to inefficient preclinical models that recapitulate human disease. To overcome this, I recently developed an orthotopic in vivo model to systematically study lung cancer metastasis and identified Capicua (CIC) as a novel suppressor of metastasis. My research aims to therapeutically stabilize CIC with clinically approved small molecule inhibitors to prevent and limit tumor dissemination and improve outcomes for lung cancer patients.